Expansion and Maintenance of Pennsylvania's State Food and Feed Laboratory Services in response to FSMA, the Laboratory Accreditation Rule, and the FDA Integrated Food Safety System

Abstract
As a large state with a population of nearly 13 million, and an economic value of 6.1 billion
dollars in Pennsylvania agriculture, it is of primary importance for Pennsylvania to possess and
maintain a laboratory dedicated to the analysis of food and feed products capable of producing
defensible results concerning the safety and integrity of the products produced by and sold within
the Commonwealth. These analytical results play a critical role in statewide and nationwide
decision making for public policy production and public health protection.
In 2020 the Laboratory Division of the Pennsylvania Department of Agriculture (PDA) Bureau
of Food Safety and Laboratory Services (“Laboratory”) began its participation in the first
iteration of the FDA Laboratory Flexible Funding Model Cooperative Agreement (LFFM) with
the primary goal of improving testing capability and capacity for human and animal food
contaminants while expanding the Laboratory’s methodologies under its ISO 17025:2017
accreditation scope. In 2025 the Laboratory intends to apply for the second iteration of the FDA
LFFM Cooperative Agreement with a focus on contribution to a national food safety
preventative approach through routine surveillance, further enhancement of the Laboratory’s
capacity and capability for product testing, and maintenance of the Laboratory’s emergency
response and preparedness. PDA’s participation in the cooperative agreement will align with the
FDA’s goal to equip state partner laboratories with additional resources to build state food
laboratory testing capacity, ultimately, strengthening FDA’s efforts to prevent foodborne illness
nationally through an integrated food safety laboratory network.

Public health relevance
Project Narrative Food and feed safety laboratories produce scientifically defensible lab results that drive creation of sound policy, prevent harmful goods from reaching consumers at marketplace, and protect the health of the public from food and feed adulteration or pathogenic outbreaks. Participation in this cooperative agreement affords the opportunity to monitor known hazards in consumer products and contribute to the national database of findings used to identify trends and problems that affect public health. Laboratory capacity and capability expansion through this opportunity bolsters public health emergency response and ensures active participation in the goal of forming a fully integrated food safety system.